Developing an Intervention to Promote Early Introduction of Peanut and Egg to Reduce Food Allergy Risk

PROJECT SUMMARY/ABSTRACT
This K23 Career Development Award will support the applicant’s long-term career goal of becoming an
independent researcher creating behavioral interventions to promote preventive care and improve disease
management among pediatric allergic diseases. The proposed study will develop an adaptive, behavioral
intervention to support caregivers with the early introduction of peanut and egg in infants’ diets: the Supportive
Training in the Early Presentation of Food Allergens (STEP-FA) intervention. Randomized controlled trials
(RCTs) have demonstrated a reduction in the onset of certain food allergies (FAs) from introducing allergenic
foods early. Adhering to early introduction recommendations is challenging; less than 20% of infants are
estimated to have consumed peanuts or eggs before 7 months. Modifiable barriers to early introduction
guidelines include practical problems (e.g., food preparation challenges), infant feeding difficulties (e.g., food
refusal), and caregiver anxiety about allergic reactions. An intervention approach that does not increase clinic
burden and is tailored to the dynamic process of early introduction is needed.
The objective of this proposal is to develop, refine, and evaluate the feasibility and acceptability of an
adaptive, behavioral intervention to improve adherence to the early introduction of peanut and egg. Community
partners from a range of racial, ethnic, and socioeconomic backgrounds will guide the development of
intervention content to ensure that STEP-FA meets families’ needs regardless of family resources or health
care barriers. The aims of the study are to: 1) develop intervention components promoting early introduction of
peanut and egg with ongoing feedback from key community partners, 2) refine the intervention with caregiver
input, 3a) evaluate the feasibility and acceptability of the intervention, and 3b) create a comprehensive action
plan for the preparation of STEP-FA for a future clinical trial. The long-term goals of the project are to decrease
barriers to the early introduction of food allergens and to improve the clinical capacity to reduce the onset of
FAs.
A comprehensive training plan will enable the applicant to conduct the proposed research and receive
individualized training to facilitate her development as an independent investigator. Through the mentorship
and training activities provided by this K23 award, the applicant will 1) build intervention development skills, 2)
develop methodological expertise in adaptive and tailored interventions, 3) gain specialized training in
developing community partnerships and conducting community-engaged research, and 4) gain increased
knowledge of emerging areas of FA prevention and treatment approaches. The applicant’s training plan is an
excellent fit with the career development opportunities at Rhode Island Hospital and Brown University’s Alpert
Medical School. Findings from the proposed study will support a future RCT examining the efficacy and optimal
implementation of the STEP-FA intervention with the long-term goal of reducing the prevalence of pediatric FA.

Public health relevance
PROJECT NARRATIVE The rising prevalence rates of pediatric food allergy (FA) is a significant public health concern. Despite a promising new approach to reducing the onset of peanut and egg allergy through early and regular ingestion of these foods, findings indicate that families have difficulty beginning the introduction process and maintaining allergenic foods in their infants’ diets. The proposed project seeks to engage key community partners to develop, refine, and explore the feasibility and acceptability of an adaptive, behavioral intervention supporting caregivers with the early introduction and maintenance of peanut and egg in their infants’ diets, with the ultimate goal of reducing rates of peanut and egg allergy among children.